Mechanisms of RNA localization and centrosome regulation

PROJECT SUMMARY:
Centrosomes are multifunctional organelles that organize the microtubule cytoskeleton required
for mitotic spindle formation, enabling chromosome segregation and safeguarding genomic
stability. During interphase, centrosomes also contribute to intracellular trafficking, cell polarity
and migration, and ciliogenesis. Centrosomes undergo cell cycle-dependent oscillations in
composition and organization to modulate their activity and diversity of functions. Prior to mitotic
onset, centrosomes increase their microtubule-organizing activity through a process called
centrosome maturation involving the recruitment of centrosomal proteins to the pericentriolar
material. RNA is also recruited to centrosomes before mitotic entry. Our research contributes to
an emerging model whereby local RNAs and on-site translational control influence centrosome
activity. While RNA localization to centrosomes is conserved across metazoans, we still lack a
complete understanding of which RNAs localize to centrosomes, how they get there, and their
biological functions. The overarching goal of our research program is to investigate how
posttranscriptional mechanisms instruct centrosome activity. The proposed work examines how
local RNA directs centrosome function by determining the basis for cell cycle-dependent
oscillations in RNA enrichment, conserved regulatory paradigms, and the unbiased discovery of
novel regulators. To achieve these goals, we utilize genetically tractable models and
multidisciplinary approaches. These studies will provide new insights into how centrosomes
regulate their activities and may inform how centrosome dysfunction contributes to
developmental disorders, neurodegeneration, and cancer.

Public health relevance
PROJECT NARRATIVE: Centrosomes are microtubule-organizing centers that coordinate diverse cellular functions, such as elaboration of the mitotic spindle or directing intracellular trafficking during interphase. How centrosome activity is regulated throughout the cell cycle is incompletely understood, yet essential for genome stability and healthy development. This study investigates how posttranscriptional mechanisms instruct centrosome function.